Positional Marking of RNA Modifications

Project Summary/Abstract
RNA modifications, which constitute the epitranscriptome, play vital roles in seemingly all aspects of RNA
metabolism and RNA’s role in the Central Dogma. More than 170 naturally occurring chemical modifications to
RNA are known, more than 60 of which are found in human RNA of all types: mRNA, tRNA, rRNA, lncRNA, and
the others. These modifications are dynamic; their global quantities change in development and during disease
progression. They are installed by writer enzymes, read by reader proteins and removed by eraser enzymes,
and they have an intrinsic capacity to alter RNA structure and dynamics. They influence translation initiation and
termination, translation fidelity, alternative splicing, trafficking between cellular compartments, and regulate RNA
degradation. RNA reader, writer and eraser proteins are promising drug targets of high current interest to
pharma. Despite this significance, no currently existing analytical method is capable of locating multiple RNA
modifications simultaneously with precise locus information and stoichiometry. The focus of this application is to
de-risk a positional marking approach to RNA modification analysis that is capable of multiplexing, approaching
single base resolution. This technology will be significant because it will provide the first commercial method for
profiling and correlating changes of multiple RNA modification types across the entire transcriptome in a given
sample.

Public health relevance
Project Narrative Alida Biosciences is a start-up company focused on reading the epitranscriptomic code, a regulatory layer of biological information controlling how the genetic code is used in cells in health and in disease progression. By creating and commercializing the first methods for reading multiple elements of this epitranscriptomic code simultaneously, we will enable new science to understand the progression of diseases such as cancer and accelerate drug development targeting epitranscriptomic pathways.